Arkansas Integrative Metabolic Research Center

PROJECT SUMMARY
The Arkansas Integrative Metabolic Research Center (AIMRC) is a Phase I COBRE at the University of Arkansas
at Fayetteville (04/01/2021-02/28/2026; PI: Dr. Kyle P. Quinn). The overall scientific objective of the AIMRC is to
investigate the role of cell and tissue metabolism in disease, development, and repair through research involving
advanced imaging, bioenergetics, and data science. The long-term objective of the AIMRC is to establish a
sustainable interdisciplinary research center that can support biomedical research at the U of A and grow the
emerging strengths in metabolic research on the University of Arkansas campus. The Bioenergetics Core
currently assists researchers with measurements of metabolic flux at the cell, isolated tissue, and whole animal
levels. Through the acquisition of an LC/Q-TOF mass spectrometer, this supplement will add the first and only
metabolomics capabilities on our campus. The comprehensive measurement of metabolites through the LC/Q-
TOF system will enable researchers to identify changes in flux through specific metabolic pathways and will
complement other sophisticated core instruments (including three Agilent Seahorse analyzers, an Oroboros O2
respirometer, BioTek Cytation 5 Imaging Multimode analyzer, and a Promethion metabolic cage system).
Collectively this suite of equipment will allow the AIMRC to provide valuable metabolic information under different
disease conditions at the molecular, cellular, tissue, and whole-body levels. Acquisition of the LC/Q-TOF mass
spectrometer will also help in obtaining a clear description of metabolites across a diverse set of biomedical
applications, and would enable the analysis of key biochemical pathways altered in functional genomics and
proteomics studies. More, importantly, the LC/Q-TOF will provide a unique resource to our campus and region.
It will be highly beneficial for the research proposed by current AIMRC COBRE research project leaders and
recruited new faculty who will be candidates for future advancement to research project leaders.

Public health relevance
PROJECT NARRATIVE We propose to install an Agilent LC/Q-TOF mass spectrometer that is capable of sensitive measurements of metabolites, allowing researchers to identify flux through different metabolic pathways in a variety of biomedical experiments. The results from the LC/Q-TOF system can seamlessly integrate with the respirometry data acquired through existing AIMRC Bioenergetics core equipment to provide a comprehensive assessment of cell metabolism.